UAB Pilot Center for Precision Animal Modeling (C-PAM) - Bioinformatics Section

ABSTRACT (BIOINFORMATICS SECTION)
The goal of the UAB Center for Precision Animal Modeling (C-PAM) is efficient analysis and modeling of
variants identified as part of rare disease programs to provide a definitive diagnosis, evaluate specific variant
impact, and support therapeutic target identification. C-PAM will accomplish this through application of
computational, cellular, and clinical methods to assist in the generation of informative animal models. As a
component of this Center, the C-PAM Bioinformatics Section (BIS) will provide the computational tools, methods,
and analyses supporting the necessary and diverse set of visualization, exploration, and analysis use cases. It
supports internal and external C-PAM users with varying skillsets and interests and supports use cases related
to both human and animal model data and the intersection between them. By tailoring existing software
infrastructure, computational approaches, and analytical capabilities, the BIS will provide the C-PAM
computational framework (portal, repository and analyses).
The BIS will: support decisions regarding selection of variants to model (Phases I, II), predict phenotypic
outcomes (Phase III), collect and disseminate data from the animal model generation process (Phases IV, V),
share data and methods with C-PAM sections and the biomedical community (Phases VI, V), and overall
support impact evaluation for C-PAM. The outward facing C-PAM portal (Aim 1) will provide data access
and analytics and a unifying view of the entire Center including an accounting of the Center's holdings and access
to data and tools. Our data schema is completely data driven and highly data condensing, allowing customization
and on-demand updates as underlying data sources update. Additionally, it is designed to support
the natural workflow of C-PAM, for example by providing users with the ability to add notes
and curations, ensuring knowledge is not lost to external notepads or apps. Also building out existing
capabilities (Aim 2), the portal will integrate a diverse and distributed set of tools and data stores supporting
consideration, prioritization, and selection of variants for model organism study. This suite of
features will support the user's ability to predict and understand phenotypic outcomes of the genetic
perturbations generated by C-PAM. Finally, the BIS will support and house cutting-edge computational research
for selection and prioritization of novel or repurposed drug targets for therapeutic decision-making (Aim 3).
Application of these innovative machine learning and other computational methodologies will
support comprehensive variant damage and drug prediction preclinical hypothesis testing and prioritization.
Across all of these aims the BIS will support the needs of diverse stakeholders, including clinicians,
patient groups, and cellular, molecular, and computational biologists. Through the approaches outlined, the BIS
will support the C-PAM goals of providing efficient and cost-effective models that can be used to help patients or
their clinicians determine the pathogenicity of a variant or aid in identification of possible treatments.